Synergy between Artificial Intelligence and DNA-Encoded Library technologies to Identify Polypharmacological Therapeutics for Substance Use Disorders

PROJECT SUMMARY
Synergy between Artificial Intelligence and DNA-Encoded Library technologies to Identify
Polypharmacological Therapeutics for Substance Use Disorders
The objective of this Phase I SBIR project is to generate synergy between Artificial Intelligence (AI) and our
own innovative and proprietary DNA-encoded library (DEL) drug discovery platform to identify novel multivalent
compounds relevant for SUDs. Each technology complements the other extremely well. The overreaching goal
is to restore, with one compound, complex brain functions impacting two, and possibly 3, important pathways.
SUDs, result from the imbalance of opioid and dopaminergic pathways affecting the reward system, the
mesocorticolimbic dopaminergic system in particular, leading to long-lasting rewiring of the brain, and involving
the brain default-mode network. We have extensively studied numerous relevant pathways, and the basal
ganglia signaling in general, in the Greengard lab.
We will identify molecules that target “2+1” neurotransmitter systems: 2 immutable systems are the opioid
and dopaminergic systems to reduce cravings and withdraw symptoms while addressing reward; 1 accessory
system will be the serotonergic system to address emotional and psychological aspects of SUDs. G protein
coupled receptors (GPCRs) constitute a crucial therapeutic category and our proposal aims to focus on the
opioid receptor delta (OPRD1) and the dopamine receptor D3 (DRD3), which, according to our expertise,
emerge as the strongest duo candidate for polypharmacology to potentially restore equilibrium to basal ganglia
signaling, without the deleterious effects of other combinations. For comorbidities including altered mood and
increased anxiety, we propose to focus on the serotonin receptor 1A (HTR1A).
The traditional High-throughput screening (HTS) drug discovery is hindered by the requirement for large
quantities of protein target, often obtained from E. coli and synonymous of non-physiological conditions, heavy
logistic and high costs. The DEL technology overcome those limitations, and it leads to large number of hits
that can come with their own limitations, especially in the context of polypharmacology. AI can replace both,
but it comes with its own limitations. The starting point of AI studies is a crystal structure that might miss
dynamism, if not plain accuracy. AI generates excessively large number of hits, that often do not exist, cannot
be made or come with exorbitant costs. We are convinced that combining DEL and AI is the ideal solution to all
of the above. DEL is cost-effective and is based on tangible compounds made in 3 steps, using a real receptor
that can react to the presence of co-factor and ligands, and generate lists of hits perfectly compatible for AI, to
search for multi target directed ligands (MTDLs).
In Aim 1, we will focus on DEL screening of OPRD1 and DRD3, produced in mammalian cells and purified
using a state-of-the-art, detergent-free protocol. 125 million DEL compounds will be used plus an extra million
of DEL compounds specifically designed for GPCRs, and the resulting material submitted to next-generation
sequencing (NGS). In-silico analysis of 4 data points will reveal the top 1,000 preferred hits for each receptor.
Aim 2 will leverage AI and computer-based methods to address polypharmacology and select compounds that
have the capacity to bind both receptors based on docking scores. A shorter list of such MTDLs will be then
subjected to docking on HTR1A. A multi-parameter optimization step will prioritize hits based on ADMET
values. Aim 3 will involve the chemical synthesis of on-DNA and off-DNA compounds. Each hit will be
validated for binding, followed by activity assessment in mammalian cells. The program aims to identify and
validate dual/triple compounds with a KD the low macromolar range or lower, and demonstrate receptor
activity. This achievement will serve as a robust proof of concept, fully validating Phase I and providing a solid
foundation for initiating Phase II with 3-5 compounds.

Public health relevance
Project narrative: Substance use disorders (SUDs) stem from disruptions in several brain signaling pathways, affecting the opioid and dopaminergic systems, with notable impacts on G-protein-coupled receptors (GPCRs), a key therapeutic category in FDA-approved medications. Among these, some are particularly promising targets for restoring impaired brain pathways crucial for SUDs, and the concept of polypharmacology (1 drug acts on several targets/pathways) seems especially relevant for SUDs. This Phase I SBIR proposal introduces a unique hybrid method that seamlessly integrates AI with wet lab drug discovery (DNA-encoded library or DEL), offering a novel and powerful approach to rectify chronically perturbed signaling abnormalities and advance polypharmacological treatments for SUDs.